Optimizing Usability, Generalizability, and Impact of CAPNET Multicenter Child Abuse Research Network Data

PROJECT SUMMARY/ABSTRACT
Over 120,000 children are identified as physical abuse victims in the U.S. annually, which is an underestimate
as medical providers frequently fail to identify the abusive origin of injuries. In response to the critical need for
evidence-based research to inform equitable recognition, evaluation, and care of victims of suspected physical
abuse, CAPNET launched in February 2021 as the first multicenter child physical abuse research network
designed to support multiple concurrent studies. CAPNET's mission is to make the care of potentially abused
children more effective, safe, and fair. CAPNET collected detailed clinical data on >12,000 children undergoing
evaluations for physical abuse at 10 pediatric centers. The goal of this proposal is to archive CAPNET's rich,
complex data and increase its usability, generalizability, and impact through investigator support tools, linkage
with external datasets, and dissemination of CAPNET data and research products. Increasing the usability of
CAPNET's complex data is necessary to support ongoing high-quality research. With NICHD R24 funding, the
CAPNET Data Coordinating Center (DCC) provided tailored, resource-intensive guidance to individual study
investigators. Given high-demand for CAPNET data and upcoming end of R24 funding, there is a need to
streamline this process to increase sustainability by (1) making CAPNET data more user-friendly and by (2)
ensuring resource-efficient development and distribution of analytic datasets. In addition, linkages of CAPNET
data with hospital and community-based data are needed to broaden the impact and generalizability of
CAPNET studies. CAPNET has created a rich, clinical data source, but CAPNET only collects information on
children undergoing evaluations by child abuse pediatrics specialists (CAPs) and not the wider denominator of
children presenting with similar injuries and not referred for CAP evaluation. The Pediatric Health Information
System (PHIS) administrative dataset captures all children evaluated in the emergency and inpatient setting at
7 of 10 CAPNET hospitals. Linkage with PHIS will facilitate research on disproportionality in abuse evaluations
as well as validation of use of ICD-10 codes in abuse epidemiology research. Finally, CAPNET data has
primarily been used by CAPs; we seek for CAPNET to be a resource for the wider research community. We
will address these needs through the following aims: (1) increase accessibility, efficiency, and usability of
CAPNET data, (2) harmonize CAPNET data with hospital and community-level data to increase generalizability
and impact, and (3) promote awareness and use of CAPNET data, research products, and resources among
researchers and policy makers. Completion of these aims will maximize impact of NICHD's R24 investment in
CAPNET through ongoing rigorous research. Products of this proposal will be (a) an archived CAPNET master
dataset containing data from >12,000 children harmonized with hospital and community data from which the
DCC will generate user-friendly, study-specific datasets, (b) technical support tools to inform the rigorous use
of CAPNET data, and (c) dissemination products and engagement tools.

Public health relevance
PROJECT NARRATIVE There is a critical need for evidence-based research to inform the recognition, evaluation, and care of victims of suspected child physical abuse. CAPNET serves as the first multicenter child physical abuse research network designed to support multiple concurrent studies towards the goal of making the care of abused children more effective, safe, and fair, and to date has collected clinical data on >12,000 children undergoing subspecialty evaluations for abuse. The goal of this proposal is to archive CAPNET's rich, complex data while increasing its usability, generalizability, and impact through development of investigator support tools, linkage with external datasets, and dissemination strategies to promote use of CAPNET data and research products by the larger research community.